Charles R. Drew University of Medicine and Science Research Endowment Program

Charles R. Drew University of Medicine and Science (CDU) proposes the Endowment for Learning Health Systems and Learning Health Communities to create a Learning Health Systems and Learning Health Communities (LHSC) Core. The Sustaining Faculty Development & Community Engagement Endowment was established to house infrastructure at CDU that facilitates biomedical research across all schools and colleges, each of which strives to enhance scientific workforce by training students in the priority areas of research including cancer, infectious diseases, cardiometabolic, mental health, substance abuse, and health services and policy. Previous endowment efforts have resulted in the creation of the Division of Community Engagement, which supports a community faculty track and community/healthcare partners; the Student Research Core; and the Health Services Research Center (HSRC) to support health services and policy research. The proposed endowment plan’s overarching goal/mission is to expand and extend the Sustaining Faculty Development & Community Engagement endowment’s research capacity with regard to community-engaged research (CEnR) and its health services and biomedical research to address health, and to enhance the scientific workforce at CDU and its surrounding community. CDU proposes to create a Learning Health Systems and Learning Health Communities Core within its Sustaining Faculty Development & Community Engagement endowment, a collaboration primarily with (but not limited to) the HSRC, the Division of Community Engagement, the Bioinformatics Core, and the Student Research Core to enhance the capacity to conduct cancer, infectious diseases, cardio-metabolic, mental health, substance abuse, and health services research and increase the scientific workforce.
The following three specific aims are proposed:
Specific Aim 1: To enhance institutional research capacity and research infrastructure across all CDU schools and colleges by developing a Learning Health System and Communities (LHSC) Core with a focus on, but not limited to, health services and community-engaged research.
Specific Aim 2: To enhance the scientific workforce in health research by creating a pipeline for masters and doctoral programs for all students and plan a doctoral program in biomedical sciences.
Specific Aim 3: To effectively manage the endowment portfolio at a level consistent with the highest fiduciary standards in the United States.

Public health relevance
CDU proposes to create a Learning Health Systems and Learning Health Communities Core to enhance the capacity to conduct cancer, infectious diseases, cardio-metabolic, mental health, and health services research and increase the scientific workforce.